Development and feasibility testing of a novel intervention to implement trauma triage guidelines

ABSTRACT
Trauma triage predisposes to diagnostic errors because of the need for decision making under conditions of
uncertainty and time-pressure. Diagnostic errors increase mortality, disability, pain, and loss of independence.
Elderly patients are particularly vulnerable because they not only disproportionately experience these errors
but also lack the resilience to tolerate sub-optimal care. The absence of interventions to improve the diagnostic
process is a critical barrier to alleviating the burden that injury imposes on patients. In prior work, our team
developed two customized, theoretically-based video games to improve the recognition of severely injured
patients. The games had moderate efficacy in the laboratory, despite only variable success at engaging
participants in the task. Our overarching hypothesis is that by increasing engagement we can amplify the
potency of the interventions. The objective of this R21 proposal is to test the feasibility of using deliberate
practice – goal-oriented training in the presence of a coach who can provide personalized, immediate feedback
– to increase engagement. The research design involves recruitment of a national convenience sample of
board-certified emergency physicians who will serve as trainees (n=30), pairing of the trainees with a coach,
delivery of three 30-minute coaching sessions using the existing games as the training task, and assessment
of the effect of the combined intervention on performance in the laboratory. The specific aims of the R21 are:
1. To assess the fidelity of intervention delivery by measuring coaching skill acquisition, coaching skill drift
and protocol adherence.
2. To assess the potential effect size of the intervention by comparing trainee performance on a validated
virtual simulation with a control group of physicians (n=30).
3. To assess the acceptability of the intervention by using a mixture of validated instruments and semi-
structured debriefing interviews with trainees to assess their engagement with the intervention.
Results will inform a future trial to compare the efficacy of different behavioral interventions in reducing
diagnostic error in trauma triage, and in the long-term should help to mitigate the burden imposed by trauma on
the health and independence of the aging.

Public health relevance
PROJECT NARRATIVE Diagnostic error compromises patient outcomes after injury, and is particularly prevalent among the elderly. One of the critical barriers to reducing preventable deaths after injury is the absence of interventions that effectively improve the cognitive processes that physicians use to make diagnoses. The objective of this proposal is to test the feasibility of using deliberate practice (goal-oriented training) to reduce diagnostic error in trauma.